Targeted proteomics technology for accurate quantitative single-cell proteomics

ABSTRACT
Multi-omics characterization of a broad spectrum of small subpopulations of cells between tumors and within
individual tumors at the single-cell resolution is crucial to achieve understanding of a complete disease biology.
Furthermore, biologically important clinical specimens are available in low quantity (e.g., <10 tumor cells),
requiring advanced single-cell technologies for effective analysis. However, single-cell proteomics technologies
are lagging far behind other omics technologies. Antibody-based immunoassays are used primarily for targeted
single-cell proteomics, but they have inherent limitations (e.g., low multiplex), and generally lack quantitation
accuracy. Mass spectrometry (MS)-based targeted proteomics has emerged as an alternative for broad accurate
quantification. However, current single-cell MS can only allow for relative quantification of ~870 proteins from
single mammalian cells. There are three major challenges in single-cell MS for accurate quantitative single-cell
proteomics: 1) ineffective processing of single cells, 2) insufficient MS sensitivity and low sample throughput,
and 3) lacking well-characterized universal internal standard (UIS). To address these challenges, we propose to
develop a single-cell MS system for rapid accurate analysis of single-cell proteome. The feasibility is strongly
supported by our recent progress in many aspects of technology development (e.g., introducing the `carrier'
concept for effective processing of small numbers of cells including single cells, and developing disruptive MS
technologies to improve MS detection sensitivity and specificity) as well as our extensive experiences in high-
resolution liquid chromatography (LC) separation for sensitive detection and targeted proteomics analysis for
absolute quantification of signaling pathway proteins. The single-cell MS system will be developed through
1) establishing super-SILAC (stable isotope labeling with amino acids in cell culture) as both proteome carrier
and UIS, 2) incorporation of proteome carrier super-SILAC (cSILAC) into the sample preparation workflow for
robust processing of single cells, and 3) leveraging cutting-edging LC and MS technologies developed at PNNL
with integration of ultralow-flow LC separation, high-efficiency ion source (the combination of an emitter array
technology and sub-ambient pressure ionization with nanoelectrospray), and ultrafast high-resolution ion
mobility separation for significantly improving both MS sensitivity and sample throughput. Super-SILAC will
be characterized as UIS for absolute quantification with crude peptide standards, whose purity will be cost-
effectively accurately determined using a combined lanthanide labeling and ICP-MS method. With 96-well
plate-based cSILAC preparation and well-characterized UIS, the new single-cell MS system is expected to allow
for rapid accurate quantification of a large fraction of human proteome (~60%) in single cells with
~120 samples per day. We anticipate that the new MS system will eventually become a convenient
indispensable tool not only for quantitative single-cell proteomics but also for routine analysis of very small
samples (e.g., rare cells). In turn, it will make substantial contributions to current biomedical research.

Public health relevance
NARRATIVE Heterogeneity is inherent in cellular processes. In disease evolution (e.g., cancer) there is extensive genetic and phenotypic diversity between tumors (intertumour heterogeneity) and within individual tumors (intratumour heterogeneity). However, there is an unmet technical challenge for comprehensive proteomic characterization of tumor heterogeneity. We aim to develop a new proteomics technology for enabling routine, rapid, accurate comprehensive characterization of the diverse heterogeneity of tumor cells to meet current biomedical needs.